Center for Effective and Accessible Research-based Testing for Health (C-EARTH)

Abstract: The Center for Effective and Accessible Research-based Testing for Health (CEARTH)
will catalyze multi-disciplinary research approaches involving individual- and policy-level
solutions to address HEW, specifically extreme heat. The aims of C-EARTH are to: Create new
research capacity for the development and evaluation of HEW solutions to address the consequences of heat and improve health, catalyze collaborations across disciplines, support career development of early-stage investigators, oversee a community-based pilot grant program on HEW solutions, and provide data infrastructure and heat tracking systems (Administrative Core); Identify HEW effects, individual needs, and test HEW evidence-based solutions in partnership with community health workers and nonprofit organizations (Research Project); Engage with community partners to cultivate trust, communication, and shared decision-making towards implementing HEW solutions that improve health (Community Engagement Core); Catalyze HEW implementation science and participatory research to implement and evaluate evidence-based solutions to address HEW and improve health by providing qualitative and quantitative analytic support, policy translation, and capacity-building initiatives for researchers and local leaders (Implementation, Solutions, and Evaluation Core). The C-EARTH leadership, research, and multidisciplinary team brings complementary expertise in community engagement, environmental and population health research, nutrition, implementation science, cost-benefit analyses, and national and international HEW policy – thus enabling multidisciplinary solutions-oriented research. C-EARTH will be instrumental in building the capacity to develop and test evidence-based solutions with opportunities for replication and scalable solutions to maximize impact.

Public health relevance
Extreme heat events are an increasing threat to public health, causing illness, death, and disruptions to food and water supplies. This project will develop and test practical, community based solutions to reduce the health risks of heat stress. By partnering with local organizations and adapting interventions to community needs, this research will provide evidence on effective and scalable strategies to prevent heat-related health problems. The results will guide public health action and policy to better protect US populations from extreme heat now and in the future.